REGULATION OF THE ACTIN FILAMENT POINTED END DYNAMICS IN HEALTH AND DISEASE

In striated muscles, actin thin filament architecture is critical for efficient contractile activity, and
alterations in thin filament integrity are linked to severe and often lethal skeletal and cardiac
muscle diseases. Our long-term goal is to identify the components and molecular mechanisms
regulating actin architecture in striated muscle during normal development and disease. In this
project, we will evaluate how actin-binding proteins of the tropomodulin family (e.g. leiomodin, or
Lmod, and tropomoduin, or Tmod) affect the formation and then the structure of the thin filament.
We will test our recently proposed molecular mechanism for the Lmod/Tmod-dependent
regulation of the pointed end of the thin filaments. We will also study the structural and functional
consequences of Lmod binding to sides of the already formed thin filaments. Finally, we will
establish mechanisms of regulation of Lmod functions. We propose three aims to identify
underlying molecular mechanisms of the full spectrum of Lmod functions: (1) to decipher the role
of Lmod in the maintenance of proper thin filament lengths via pointed end regulation; (2) to
establish the role of Lmod’s actin-binding sites in thin filament activation; (3) to test the hypothesis
that Lmod functions are regulated by Ca2+. Our data will provide a comprehensive identification
of critical components of the regulatory mechanisms underlying thin filament assembly and
maintenance in health and disease.

Public health relevance
The proposed research is relevant to public health because alterations in thin filament lengths in muscle sarcomeres have been linked to the development of myopathies. In this study, the regulatory role of leiomodin in thin filament organization and function will be studied.